Gene Expression and Manipulation

PROJECT SUMMARY - GENE EXPRESSION AND MANIPULATION
The Gene Expression and Manipulation Module is focused on providing support, and assisting and facilitating
specific studies relating to gene expression and manipulation. Most of the types of studies we support fall within
the range of ocular molecular biology, biochemistry and cell biology. This includes evaluating, quantitatively, the
temporal effects of treatments, conditions or disease states on the expression levels, mRNA and protein, of
genes in ocular tissues. We also support studies focused on determining the effects of individual gene
manipulation on ocular processes and cells. This includes knockdown of specific gene expression levels in cells
or tissues by RNAi silencing, increases in specific gene expression by overexpression, and modulation of activity
or function of specific genes by expressing modified forms, e.g. by transfecting or infecting genetic mutant,
dominant negative, constitutively active or alternatively spliced gene constructs. Manipulation methods include
construct transfection and viral gene or RNAi delivery via infection with recombinant viral constructs. Expression
studies using PCR Arrays and cis element promoter studies are also facilitated. We have recently been assisting
investigators with CRISPR/Cas9 gene editing studies aimed at disease modeling with the intention of future
disease related modifications and stem cell manipulation. We have and maintain instrumentation that supports
these types of studies. We have experience with all of these methods and will facilitate and assist core users
with any that they deem of value to their investigations. In addition to providing this service to NEI-funded
investigators, we actively support efforts of investigators, particularly new and young investigators, to develop
pilot or preliminary data that can be leveraged into future foundation and NEI funding.